SC Biomedical Informatics & Data Science For Health Equity Research Training (SC BIDS4HEALTH)

ABSTRACT
The South Carolina Biomedical Data Science and Informatics for Health Equity Research (SC BIDS4HEALTH)
training program seeks to train informaticists and data scientists to address health disparities, via engagement
with local communities, using telehealth services and informatics tools to improve access, through interoperability
and enhanced health information exchange, through improved healthcare quality (particularly in rural and critical
access hospitals) and through novel, health disparities focused e-health innovations. Given that chronic illnesses
underlie health disparities in South Carolina, the development of our curriculum is based on application of the
Wagner model of chronic illness care to address healthcare related disparities through informatics to make chronic
care for those with disparities more available and effective. This model provides a framework to enhance health
systems for those at risk of disparities, using informatics and data science driven approaches to improve health of
at-risk individuals through more effective, patient-centric healthcare. The SC BIDS4HEALTH builds on an
existing joint Clemson University – Medical University of South Carolina PhD program in Biomedical Data Science
and informatics and that involves faculty who are nationally and internationally recognized leaders in biomedical
informatics, public health, computer science and engineering, and multiple biomedical and health domains. We
leverage many existing resources and partnerships to enable curriculum that both provides state-of-the-art
training and makes a notable impact on South Carolina communities, especially those that are medically
underserved. Through these same partnerships, we create pathways into our program from local historically
black colleges and universities. We hypothesize that systematic training in SC BIDS4HEALTH is achieved by
(Aim 1) synthesizing new didactic curricula building on the foundations of Biomedical Informatics, Data Science,
and Population Health to achieve understanding of how these concepts can be applied in rural and underserved
populations, to advance health and alleviate health disparities; (Aim 2) developing new immersive practical and
research experiences in affected communities to allow for direct trainee interactions and measurable impactful
research outcomes; (Aim 3) providing teaching experiences to the pre-doctoral trainees and promote exposure
of HBCU students to biomedical data science and informatics research and careers; and (Aim 4) developing a
new postdoctoral training program. We further propose to (Aim 5) evaluate the careers and community impact
of the SC BIDS4HEALTH training program. The predoctoral program is 2 to 3 years in length, while the length of
the postdoctoral program is 1 year with possibility of renewal for another year. At full capacity, this program will
simultaneously support 10 predoctoral and 4 postdoctoral trainees across Clemson and MUSC.

Public health relevance
PROJECT NARRATIVE South Carolina Biomedical Data Science and Informatics for Health Equity Research (SC BIDS4HEALTH) training program combines rigorous curriculum in biomedical informatics, data science, population, health systems and policy, and domain biology based on existing joint PhD degree in Biomedical Data Science and Informatics with coursework and practical experiences in understanding diversity and career readiness skills. The training program includes predoctoral and postdoctoral components. The faculty mentors in the program are nationally and internationally recognized leaders in biomedical informatics, public health, computer science and engineering and multiple biomedical and health domains.